Studying NeuroHIV and addictive substances in a human microglia-neuron chimera mouse model

PROJECT SUMMARY
HIV and substance use disorder (SUD) alter brain functions, but current in vitro and in vivo models fail to replicate
the complexity and sanctuary role of the central nervous system (CNS) accurately. New preclinical models that
appropriately incorporate relevant human CNS cell types targeted by HIV and addictive substances are urgently
needed. The long-term goal is to enable deep molecular phenotyping of NeuroHIV to develop targeted
therapeutic and potentially curative strategies for people with HIV and SUD. The overall objectives of this
application are to establish a novel mouse model for NeuroHIV that mimics the human CNS environment and
characterize the impact of ART and addictive substances on HIV persistence and neuroinflammation to validate
this model for preclinical research. These objectives will be accomplished in a two-phase, milestone-driven
approach. In the exploratory phase (R61), Aim 1, a chimeric humanized microglia-neural cell (huMGN) mouse
model that includes human microglia, neurons, and astrocytes, differentiated from induced pluripotent stem cells
(iPSCs) will be developed in human macrophage colony stimulating factor 1 knock-in (hCSF1KI) SCID mice. In
this model, human microglia fully replace murine microglia while human neurons and astrocytes are engrafted
locally at the implantation site. The functionality of key CNS cell types, blood-brain barrier (BBB) integrity, as well
as reproducibility with iPSCs from diverse genders and ethnicities will be thoroughly evaluated before optimizing
HIV infection with different CCR5-tropic viral strains using systemic and localized infection routes. Viral loads,
neuropathology, and inflammation in distinct CNS cell types will be assessed and compared to mice with
CCR5∆32-iPSC-derived engraftments. By the end of the R61 phase, the team will have established a robust
model with reproducible engraftment success rates (≥70%) across diverse iPSCs and identified ≥1 optimal HIV
infection protocol with infection rates ≥3% in relevant CNS cell types to progress to the R33 phase. In this phase,
Aim 2 will introduce different ART regimens into infected mice and examine treatment effects on viral replication,
latent reservoir size, BBB integrity, and neuroinflammation. In Aim 3, infected huMGN mice will be exposed to
intravenous morphine, and its effect on viral load, neuroinflammation, and BBB integrity will be assessed and
compared to mice treated with µ-opioid receptor (MOR) antagonist or engrafted with ∆MOR iPSCs. Further,
single-cell transcriptomics will assess whether the model faithfully reproduces molecular alterations observed in
human brains in the NIDA SCORCH program. The central hypothesis is that a highly reproducible in vivo model
of NeuroHIV can be established that is responsive to ART and is specifically designed to study HIV-associated
neurocognitive disorders in the context of SUD. The project, led by a multidisciplinary team with complementary
expertise in neuroscience, HIV biology, and clinical research, and a track record of successful collaborations, will
enable new CNS-tailored therapeutics and viral eradication treatments for people living with HIV and SUD.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it focuses on developing a novel preclinical mouse model for NeuroHIV and substance use disorder. Specifically, our model integrates human microglia, neurons, and astrocytes into the mouse brain, enabling the study of HIV, ART, and addictive substances within a complex human-like neural architecture for potential clinical applications. These studies are particularly relevant to the NIH mission of achieving a functional HIV cure, potentially transforming the treatment landscape for people living with HIV and substance use disorder.